Research Experience & Training Core

ABSTRACT
The Yale Superfund Research and Training Program (YSRTP) will foster problem-based, solution-oriented
research related to the theme of water contaminant fate, exposure, remediation, and adverse health effects. To
be most effective, this endeavor requires cross-trained scientists, engineers, and biomedical researchers with
wide-ranging communication skills to successfully address emerging research and health questions. The
proposed YSRTP unites the fields of public health, medicine, genetics, environmental chemistry, environmental
engineering, and chemical fate and transport. We will leverage this disciplinary diversity, departmental and
University resources, and YSRTP’s diverse research areas and cores to produce trainees with depth in their
specialized field, and a breadth of knowledge and professional experiences in environmental health, chemistry,
and engineering; disciplines that are important for controlling exposure to hazardous environmental chemicals.
The goal of the YSRTP Research Experience Training Coordination Core (RETCC) is to expand the breadth of
educational, research, and professional development opportunities to pre- and post-doctoral trainees. Four
specific aims are proposed. 1. Recruit a cadre of diverse, academically prepared doctoral students and post-
doctoral researchers; 2. Provide interdisciplinary training through a requirement of cross-disciplinary
coursework and focused training in community outreach, results dissemination, risk communication, and
research translation; 3. Design and implement a program for interdisciplinary research exchanges within and
external to Yale; and 4. Encourage trainee professional development through planned interactions with
community partners, government agencies, and private industry. RETCC central activities will include specific
symposia and workshops to broaden trainee education and research skillsets, mentorship programs to prepare
students for candidacy exams and monitor dissertation progress; a graduate research seminar and other
ancillary activities to encourage interaction among trainees and build a scholastic community, and an
evaluation process to continually update and improve the RETCC. Training will leverage the broader Yale
University teaching, research, and mentoring infrastructure and build synergies with the YSRTP cores in
administration (research translation), community engagement and data management and analytics.
This training core will focus on pre- and post-doctoral trainees working in the fields of chemistry, environmental
engineering, public health, and biomedical research within the YSRTP and includes an interdisciplinary
(environmental engineering and biomedical research) directorship. Specific research areas include: the effects
of water contaminants on reproductive toxicology, evaluation of 1,4-Dioxane (1.4-DX) exposure and early
biological effects in drinking water, identification of early vs. late 1,4-DX-induced liver damage and
carcinogenesis and of potential biomarkers of exposure, biosensors and chemical sensors and online
contaminant monitoring, development of next-generation, modular advanced oxidation process technology.

Public health relevance
Project Narrative The Research Experience Training Coordination Core will expand the population of professionals able to conduct and interpret research relating to human exposure to and health effects of emerging drinking water contaminants and produce cross-trained scientists, engineers, and biomedical researchers with the broad communication skills required to effectively address emerging environmental research and health questions.